Auditory function, cognition, language and brain structure in Down Syndrome- Admin Supplement

The proposed supplement is relevant to the INCLUDE project, by enhancing our understanding
of hearing loss, a co-occurring condition in Down Syndrome (DS), specifically in children. We
focus on an aspect of INCLUDE Component 1: Targeted, high risk-high reward, basic
science studies in areas highly relevant to DS. The parent grant has shown success to date
in recruitment and testing of young adults with DS, however, there is also a paucity of auditory
studies in children with DS. The incidence of hearing loss in infants and children with DS is
higher than in the general population. While the Center for Disease Control reports that up to
75% of children with DS are affected by hearing loss (Data statistics on Down Syndrome, 2019),
screening is not standard. Many children with DS who pass universal newborn hearing
screenings are identified with significant hearing loss at older ages, thus, hearing loss can go
undetected during development. If detected, the type/degree of hearing loss and thus treatment,
need to be incorporated into clinical practices that serve children with DS. The compounded
impact of hearing loss on developmental delays that occur in children with DS remains
unknown. The goal of the supplement is to collet pilot data in children with DS,
establishing feasibility for a new parent R01 on auditory function and its association with
cognition, language and brain structure and function in children with DS. The research will
be conducted at the Waisman Center, a premier research institute at the University of
Wisconsin Madison, where the PI's lab is situated. Waisman is one of the named Intellectual &
Developmental Disabilities (IDD) Research Centers in the US, where scientific discovery is
aimed at advancing knowledge and developing treatment in developmental disabilities. This
project will leverage important, unique resources at the Waisman Center: (1) Auditory
perceptual measures of hearing speech in noise, spatial hearing and brain function using EEG
were developed for young listeners in the Litovsky lab, recently implemented in the parent R01
for young adults with DS, will be piloted and revised as needed for a younger population of
children with DS. (2) Cognitive measures and MRI neuroimaging to evaluate brain structure are
well established in the Hartley's lab, and in the Alexander lab, respectively. (3) The Waisman
Center will be launching a new research cohort development project, under Hartley's leadership,
that will bring dozens of children with DS to the Waisman Center, providing a robust participant
pool for this supplement.

Public health relevance
The proposed supplement is relevant to the INCLUDE project, in which the parent grant focuses on adults with Down Syndrome (DS), specifically, associations between hearing status, auditory function, cognition, language and brain imaging through functional and structural approaches. This supplement aims to collect pilot data in children with DS, as there is a paucity of auditory studies in this population, with known incidence of hearing loss in infants and children with being much higher than in the general population. This supplement will provide pilot data in children with DS, establishing feasibility for a new parent R01 on auditory function and its association with cognition, language and brain structure and function in children with DS.